EFFECT OF SOMATROPIN TO IMPROVE THE HEIGHT DEFICIT WITH RENAL INSUFFICIENCY

This study is to determine if supplemental human growth hormone given to children with chronic renal insufficiency will improve the growth deficit known to accompany CRI.